The University of Chicago and Northwestern University Predoctoral Health Services Research Program-Renewal

PROJECT SUMMARY/ABSTRACT
The University of Chicago is requesting continued support from the Agency for Healthcare Research and
Quality (AHRQ) for the National Research Service Award (NRSA) program entitled the University of Chicago
And Northwestern University Predoctoral Health Services Research Program (UCANU Predoctoral HSR
Program), a joint predoctoral training program that began in 2013. The program will provide two to three years
of support to outstanding candidates from participating predoctoral programs from both University of Chicago
(UC) and Northwestern University (NU): Comparative Human Development (UC), Economics (UC),
Psychology (UC), Sociology (UC), Public Health Sciences (UC), Business (UC), Public Policy (UC), Social
Work (UC), and the Health Sciences Integrated Program (NU). The UCANU Predoctoral HSR Program draws
upon the substantial and complementary resources, faculty, and expertise at both UC and NU to create new
opportunities for our trainees to develop into productive health services researchers. This program links the
well-established UC predoctoral training program that includes a strong disciplinary base with an eleven-year-
old, interdisciplinary predoctoral program at NU. The UCANU Predoctoral HSR Program will continue to
enhance the training provided by both programs by offering trainees a highly diverse group of peers and
mentors, a joint UCANU seminar where trainees can present their research, formal coursework opportunities,
and a wide array of settings in which to perform HSR. In this newest iteration, we will continue offering training
in learning health systems research and enhance program activities to provide additional focused training in
implementation science and promoting health equity. Overall, the UCANU Predoctoral HSR Program aims to
produce the next generation of highly skilled health services researchers who will have the skills to conduct
independent and collaborative research that will transform health care delivery and policy and advance health
equity.

Public health relevance
PROJECT NARRATIVE The University of Chicago And Northwestern University Predoctoral Health Services Research Program, referred to as the “UCANU Predoctoral HSR Program,” proposes to build and expand upon the first ten years of success of a unique, joint predoctoral training program to prepare social scientists and clinicians with the knowledge and methodological skills to address the most pressing issues in the US healthcare delivery system.